Dynamics of Developmental Defect Formation

PROJECT SUMMARY
Recent advances in genome sequencing have led to the identification of many mutations linked to developmental
disorders. Additionally, phenotypes associated with these diseases have been well characterized through
endpoint assays. Thus, genotype and phenotype have been separately well defined, but the connection between
the two is not clear. Identifying the point in development that is most vulnerable to the effects of these mutations,
or the point at which there is a detectable difference from what is typically observed is essential for understanding
the pathogenesis of developmental disorders. To address these outstanding questions, live imaging approaches
are needed. The proposed work uses the larval tracheal system of Drosophila as a model for the study of
phenotypic emergence. The development of the larval tracheal system is strikingly analogous to human
angiogenesis, a process that is affected in a class of developmental diseases known as the RASopathies, the
subject of this work. Using this model system in Drosophila gene edited to carry mutations leading to elevated
Ras-MAPK signaling, the proposed work will identify the position and timing of defect formation as well as the
magnitude of change in signaling that accompanies developmental defect formation. Specifically, Aim 1 will
use endogenous live reporters of tracheal cell fates in combination with live imaging to identify the
developmental event that is affected in a mutant background. This work will provide insight into the variability
underlying phenotypic emergence. Additionally, Aim 2 will use live reporters of signaling pathways, live
imaging, and quantitative image analysis to determine the magnitude of change in signaling activity that
is associated with a change in cell fate or the formation of a defect. The work described in Aim 2 will identify
the limits of robustness of developmental signaling pathways. The proposed studies, which are supported by
strong preliminary results, including live imaging and an established image analysis pipeline, will provide a
deeper understanding of the connection between genotype and phenotype.

Public health relevance
PROJECT NARRATIVE Endpoint phenotypes resulting from genetic developmental disorders are well defined, but the molecular mechanisms underlying the emergence of these phenotypes remain unclear. The proposed work will advance the understanding of human developmental disorders by identifying the variability in developmental trajectories that lead to a similar endpoint phenotype and the magnitude by which signaling needs to be changed to lead to a qualitative phenotype.